Child Health ResearcH Career Development Award (CHRCDA) Program (K12)

Project Summary
The goal of the Boston Children's Hospital CHRCDA Program is to develop pediatrician physician-scientists
who are performing world-class research that will improve health care for children in this country and around
the world. Our Scholars will be performing laboratory-based basic and translational research under the
mentorship of outstanding scientists at Children's Hospital and other Harvard Associated Hospitals and
Harvard Medical School. Our program has been established to ensure the development of independent
scientists. In this proposal we describe a program that includes intensive mentoring, a comprehensive didactic
program, and a program to ensure the scientific development of Scholars. Programmatic oversight will be
provided by an External Site Visit Committee and an Internal Steering Committee. Plans are in place for
programmatic self-evaluation and for review of Scholar Progress.
We propose to continue the funding of three Scholar positions. Scholars will be funded for a minimum of two
years, with further funding contingent on progress and the overall pool of Scholar candidates. Scholars will be
faculty members most often at the rank of Instructor, but Assistant Professors who are early in the
development of their independent careers will also be eligible to apply. Scholars will be considered at any
point from the beginning of their Instructorship to the point where they are considered to be two years away
from submitting their first R-level NIH grant or equivalent, though no more than four years beyond the end of
fellowship training.
Scholars will work in a broad range of scientific investigations. Past and present Scholars have worked in
areas such as the mechanism of nuclear reprogramming, structural biology of malaria antigens, immune
response to tumors, cancer therapeutics, molecular bases for immunodeficiency, host-microbiome interactions,
lung and intestinal stem cells, molecular pathology of streptococcal infection, and disorders of sexual
differentiation. These investigations will elucidate fundamental molecular mechanisms and will lead to the
development of new therapeutic modalities in all areas of pediatric disease, including hematology/oncology,
endocrinology, nephrology, infectious disease, immunology, pulmonology and neurology.
!

Public health relevance
Project Narrative: The Department of Medicine at Boston Children's Hospital is dedicated to the training of physician-scientists and in helping them to develop careers as world- class independent scientists. We have a strong history of producing physician- scientists who have contributed to major discoveries in fundamental basic research and translational research that have had lasting impact on the treatment of pediatric disease. The Child Health Research Career Development Awards have played an integral role in supporting the development of physician-scientists at our institution and we propose to continue and strengthen this program over the next five years.